Molecular mechanisms of chemoresistance in breast cancer

Abstract: Apoptosis is a form of programmed cell death that plays a crucial role in normal tissue homeostasis and development. In response to various genotoxic or cytotoxic stressors, apoptosis occurs by release of cytochrome c from the mitochondria, which promotes nucleation of a structure known as the apoptosome to activate cysteine proteases called caspases. In contrast to untransformed cells, cancer cells exhibit marked resistance to apoptosis by blocking mitochondrial cytochrome c release and/or by inhibiting apoptosome formation following cytochrome c release. Overexpression of the receptor tyrosine kinase ErbB2 is known to be associated with poor prognosis in breast cancer patients. Despite the availability of ErbB2-specific molecular inhibitors, the majority of ErbB2- overexpressing breast cancers eventually develop resistance to these inhibitors over a period of time (i.e., acquired resistance), suggesting the presence of currently uncharacterized mechanisms of chemoresistance. In this proposal, I investigate the molecular mechanisms contributing to apoptotic inhibition in breast cancers with acquired resistance to lapatinib, an FDA-approved ErbB2 inhibitor. It is my central hypothesis that inhibition of apoptosome formation plays a critical role in acquired lapatinib resistance in breast cancer. This hypothesis was formulated based on evidence from our laboratory as well as from others demonstrating that apoptosome inhibition can occur by two key independent pathways: HSP90β hypophosphorylation and CAS downregulation. Apoptosome inhibition by these mechanisms may override cell death signals caused by various pro-apoptotic stimuli. Towards this end, I will pursue the following two specific aims: 1) to determine the role of HSP90β hypophosphorylation in acquired lapatinib resistance, and 2) to elucidate the molecular mechanism of CAS downregulation. My primary career goal is to obtain a tenure-track position in an academic setting at a major U.S. university. My long-term goal is to build an independent research career as a molecular cancer biologist. To achieve these goals, I hope to both develop my intellectual knowledge base as well as increase my technical skill repertoire throughout the duration of the proposed study. This training should be readily attainable in the Kornbluth laboratory at Duke University Medical Center; our lab has considerable expertise in the biochemical analysis and molecular dissection of complex signaling pathways, both during apoptosis and cell cycle progression. In addition, I have obtained two outstanding collaborators, Drs. Neil Spector and Mark Dewhirst, who are established investigators in the fields of breast cancer and mouse xenograft models of cancer, respectively. Moreover, in order to promote and assure my progress during the Career Development Award period, I have organized an advisory committee consisting of well-established senior scientists with expertise in different areas relevant to my research and career goals. Collectively, the proposed studies will provide significant insight into mechanisms of chemoresistance and potential strategies for sensitizing cells to pro-apoptotic agents. Moreover, this work will provide me with the means to establish myself as an independent investigator.

Public health relevance
Project Narrative Cancer cells are markedly resistant to apoptotic cell death. In this proposal, we focus on mechanisms of cell death dyregulation in breast cancers, particularly under conditions of acquired resistance to chemotherapeutic agents. This study should help to elucidate mechanisms of breast chemoresistance and aid in the development of novel therapeutic strategies to avoid such resistance. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS: Chemotherapeutic agents typically function by triggering a cell death program known as apoptosis, which promotes the release of cytochrome c from the mitochondria into the cytoplasm and stimulates formation of a caspase-activating complex called the apoptosome. Despite chemotherapeutic treatment, in many cases cancer cells are able to evade these death pathways by blocking mitochondrial cytochrome c release and/or inhibiting the apoptosome (termed post-cytochrome c protection). In characterizing cancer cell signaling pathways, it was discovered that the receptor tyrosine kinase ErbB2 is overexpressed in 25-30% of breast cancers and is associated with a poor clinical prognosis. These findings prompted the development of ErbB2- specific molecular inhibitors for treatment of these tumors. Unfortunately, a proportion of ErbB2-overexpressing breast cancers do not respond to treatment with such inhibitors alone (i.e., primary resistance) and a majority develop resistance to the inhibitors over a period of time (i.e., acquired resistance). My long-term goal is to develop an independent research career as a molecular cancer biologist. By utilizing biochemical and molecular biological approaches to investigate molecular defects in apoptotic signaling pathways, I hope to increase our understanding of cell death evasion in cancer. The overall objective of this application is to elucidate the apoptotic signaling pathways leading to acquired resistance to lapatinib, an FDA-approved ErbB2 inhibitor, in breast cancer cells. It is my central hypothesis that inhibition of apoptosome formation plays a critical role in acquired lapatinib resistance in breast cancer. This hypothesis was formulated based on evidence from our laboratory as well as others that apoptosome inhibition by two key independent pathways, HSP90β hypophosphorylation and downregulation of the apoptosome regulator CAS, can override cell death induction caused by various pro-apoptotic stimuli. The rationale for the proposed research is that a detailed understanding of the molecular mechanisms connecting apoptotic inhibition to acquired lapatinib resistance will significantly contribute to a cure for breast cancer. In addition, this project will provide me with the opportunity to acquire novel biochemical tools, training in the use of mouse xenograft models, and intellectual immersion in a new area of study, all of which will greatly facilitate my establishment as an independent investigator. Given my scientific background in developmental biology and my current training in molecular cellular biology, I am well prepared to reap the benefits of a K99 award. Guidance from a well-established, funded mentor in the fields of apoptosis and cell cycle, as well as a strong research environment composed of additional funded investigators performing complementary research in breast cancer, HSP90, and apoptosis, will help to ensure that I will achieve the scientific and career development goals detailed in this application. To test my central hypothesis and accomplish the objectives of this application, I will pursue the following two specific aims: 1. Determine the role of HSP90β hypophosphorylation in acquired lapatinib resistance Working hypothesis: Hypophosphorylation of HSP90β promotes post-cytochrome c protection from apoptosis and thereby contributes to acquired lapatinib resistance. 2. Elucidate the molecular mechanism of CAS downregulation Working hypothesis: Downregulation of CAS protein, the degradation of which is mediated by the E3 ligase MDM2, leads to post-cytochrome c protection and acquired lapatinib resistance. The work proposed in this application is innovative for three primary reasons. First, the regulation of apoptosome formation to be investigated here is poorly understood compared to the regulation of cytochrome c release from the mitochondria. Second, this proposal focuses on previously unknown mechanisms controlling HSP90β and CAS, both of which have been identified as key regulators of the apoptosome. Third, this research utilizes multiple cell lines with acquired lapatinib resistance as models which closely recapitulate the pathophysiological circumstances seen in a clinical setting. It is expected that downregulation of post- cytochrome c protection (by promoting HSP90β phosphorylation and/or increasing CAS to basal levels) in lapatinib-resistant cells will restore susceptibility to lapatinib-induced apoptosis. Conversely, I would expect that upregulation of post-cytochrome c protection may render breast cancer cells resistant to lapatinib. I anticipate that the proposed research will identify novel molecular mechanisms working to regulate HSP90β phosphorylation and CAS protein levels. Results from these studies will ideally position me to submit a competitive R01 application during the fourth year of the K99/R00 award period. In aggregate, the proposed studies will provide significant insight into mechanisms of chemoresistance as well as potential strategies for sensitizing breast cancers to pro-apoptotic agents. Moreover, the proposed research will provide me with the means to establish my scientific career as an independent investigator.